Role of Type I and III Interferons in Shaping Influenza A Virus Dynamics Within and Between Hosts

Summary
The central role of the interferon (IFN) cytokines in innate antiviral responses has been recognized for decades
and many of the mechanisms underlying their induction and the responses they trigger have been worked out in
molecular detail. Much less well-understood, however, is the impact of IFN on the genetic structure of viral
populations within and between hosts. We hypothesize that the restriction of viral propagation imposed by IFNs
reduces the effective size of viral populations within infected hosts and contributes to tight bottlenecks during
transmission to new hosts. Owing to their different properties, we furthermore expect differing effects of type I
IFN and type III IFN (IFN-λ). We anticipate that both will restrict diversity within an infected host, but may do so
with differing kinetics. In addition, due to its localized action within the epithelium, we expect that IFN-λ
contributes to a further reduction in effective population size during transmission between hosts. To test these
hypotheses we will leverage two valuable experimental tools. The first constitutes the application of CRISPR
Cas-9 editing to generate guinea pigs that lack either IFNAR1 or IFNLR1, the receptors for type I IFN and IFN-
λ, respectively. Guinea pigs are naturally susceptible to a wide range of influenza A viruses (IAVs) and an
excellent model for following the longitudinal dynamics of infection within a host as well as transmission to new
hosts. The second tool is an IAV population carrying a highly diverse and fitness-neutral genetic barcode.
Monitoring barcode diversity through deep sequencing will allow us to determine the impact on viral dynamics of
disrupting IFN signaling. With this combination of host and viral genetics, we are well-positioned to uncover the
effects of type I IFN and IFN-λ, the lynch-pins of mammalian innate defenses, on viral genetic diversity and
evolutionary potential.

Public health relevance
PROJECT NARRATIVE Viral evolution presents a major challenge to public health efforts designed to limit the health and economic impacts of seasonal influenza epidemics and pandemics. Our research seeks to address this challenge by elucidating the mechanisms that shape influenza A virus evolution.